Path B Kansas Department of Agriculture Produce Safety Program for theImplementation of the CFR Title 21 PART 112

Project Summary
Program Path
The Kansas Department of Agriculture, Division of Food Safety and Lodging seeks funding for the
continued operation of the Produce Safety Program. We are applying for this Cooperative Agreement
under Path B.
Summary of Proposed Activity
Program documentation will meet all FDA requirements and adhere to state laws. Program
documentation will be considered living documents that are updated as often as necessary and reviewed at
least twice per year. Role and responsibilities within the program will be reevaluated and updated as
necessary. Educational materials for produce farmers will continue to be developed, updated, and shared.
Technical assistance to program staff, related organizations (such as commodity groups), and to
individual farmers will continue to be provided by program staff. Referral to and communication with
higher level experts (such as the TAN, PSN, or FDA) will occur if technical queries exceed the
capabilities of program staff. The produce farm inventory will continue to be verified and updated on a
regular basis and as necessary. Comparison with the 2017 NASS data will be closely examined, and any
differences analyzed and explained. Inspectors will be trained to perform On Farm Readiness Reviews
and Produce Inspections. Inspectors and other key program staff will maintain FDA commissioning and
credentialing in accordance with their role within the program. Inspectors will conduct Produce Safety
Inspections in accordance with the FDA’s Inspection Assignment on behalf of the FDA. KDA inspectors
will not conduct Sprouts Inspections on a solo basis. If the assigned FDA inspector agrees to the KDA
inspector accompanying them on a Sprouts Inspection for instructional purposes, KDA produce
inspectors will participate as allowed. Any necessary compliance and enforcement issues (such as follow
up inspections, recall actions or egregious conditions) will be executed only as directed by the FDA. No
routine sampling will occur, but KDA is poised and capable of for-cause sampling if directed by the FDA.
Produce related event response will be directed by the Kansas Department of Agriculture Rapid Response
Team, with the Produce Safety staff serving as subject matter experts. Small scale events will be
addressed within the program through the compliance and enforcement policies and procedures.

Public health relevance
Project Narrative The Kansas Department of Agriculture will be able continue to operate the Produce Safety Program in the Division of Food Safety and Lodging with the funding provided by this Cooperative Agreement. The Program maintains the Kansas Produce Farm Inventory, develops programmatic policies and procedures in compliance with FDA requirements, and performs produce farm inspection under FDA commissioning/credentialing. The Kansas Department of Agriculture Produce Safety Program is seeking funding under PATH B, as specified in the Cooperative Agreement Notice of Award.